HSP90 and HSP70 Chaperone Proteins and Interactors in Cellular Signal Transduction

This research program was discontinued in late November 2024 with Dr. Neckers retirement from government service. He is best known for his work on the molecular chaperone Hsp90 which led to its identification and validation as a non-oncogenic target in cancer. Neckers also identified numerous oncogenic client proteins of Hsp90, findings that led to an understanding of how a single protein can be manipulated to target multiple oncogenes simultaneously. There are now over 200 known Hsp90 clients that have been identified as a result of Neckers' work, many of which are oncogenes.